Biospecimen Repository and Pathology Core

PROJECT SUMMARY/ABSTRACT
The Biospecimen Repository and Pathology Core is designed to provide support for the translational research
efforts of the Genomic Instability in Breast Cancer SPORE, serving the SPORE RP1, RP2 and RP3, and
developmental research projects. This Core will ensure a seamless integration of the current infrastructure
available at Memorial Sloan Kettering Cancer Center (MSKCC), and constitute an essential component of this
SPORE project, facilitating and expediting the collection, annotation, storage, distribution, and digital archiving
and processing of biospecimens from breast cancer patients with specific patterns of DNA repair defects and/or
genetic instability included in the SPORE research projects. This Core was also conceived to provide SPORE
investigators with expert histopathologic evaluation of tumor samples from breast cancer patients enrolled in the
research protocols, patient-derived xenografts and murine models described in this SPORE application, in
conjunction with comparative pathologists from the MSKCC Laboratory of Comparative Pathology and the
Genetically Engineered Mouse Phenotyping Service. The Core will also provide assistance in performing and
interpreting immunohistochemical assays, in selecting tissue for microdissection and performing these
microdissections, and in the generation of dedicated tissue microarrays. The Core will provide multiplexed
immunophenotyping of the tumor and tumor microenvironment from breast cancers and breast cancer models.
The specific aims of the Biospecimen Repository and Pathology Core include 1) to maintain and expand the
systematic collection, annotation, and storage of bio-specimens for translational research of breast cancers with
specific patterns of DNA repair defects and/or genomic instability, 2) to perform expert pathologic evaluation of
all human breast cancer and animal models of breast cancer samples with specific patterns of DNA repair defects
and/or genomic instability and preparation of appropriate material for use by SPORE investigators, and 3) to
perform detailed immunophenotypic characterization of breast cancers and animal models of breast cancers
with specific patterns of DNA repair defects and/or genomic instability. By centralizing and standardizing the
pathology review of both human and murine breast cancer samples, from both clinical and research settings,
and by working in conjunction with other Cores within MSKCC on the processing and curation of the biospecimen
materials and digital images obtained from the samples included, the Biospecimen Repository and Pathology
Core will help mitigate the impact of common confounders in translational research studies, as well as it will
assist in the integration and prioritization of a variety of institutional pathology systems-related development
efforts.

Public health relevance
PROJECT NARRATIVE The Biopsecimen Repository and Pathology Core will facilitate and expedite the collection, annotation, storage, distribution, and digital archiving and processing of biospecimens from patients with breast cancers displaying specific patterns of DNA repair defects and/or genetic instability, provide histopathology, molecular pathology and multiplexed immunophenotyping expertise and support for the seamless and timely execution of the SPORE Research Projects.